CHILDHOOD PRECURSORS AND OUTCOME IN SCHIZOPHRENIA

This application is for a continuation of my Research Scientist Development Award. During the initial period of this award, all of the major research and educational objectives were achieved. First, as a proposed, extensive data on the premorbid development and adult psychiatric outcome of a sample of 120 subjects were obtained. The data included childhood home-movies which served as the primary source of information on activity level and neuromotor and socioemotional development. Results from analyses of these films indicate that preschizophrenia subjects are characterized by an elevated rate of neuromotor abnormalities, particularly in first two years of life, and higher rates of negative affective displays throughout childhood. Retrospective ratings of childhood behavior indicated that preschizophrenia children had significantly more behavior problems than their healthy siblings. Parental ratings of behavior problems were correlated with both neuromotor abnormalities and negative affect ratings from the films. Integrative papers on the neurodevelopmental implications of these findings have also been published. With respect to the educational goals of the RSDA, the award made it possible for me to gain additional training in basic neuroscience, with specialization in the biological basis of motor functions. This exposure is reflected in the biological emphases of recent papers. The findings of this work, as well as some pilot studies recently conducted in our laboratory, led to the research proposed in the present continuation application. It also led to the proposed educational plan in neurochemistry and neuroendocrinology. The research goals involve the extension of our study of precursors to explore the longitudinal course and the correlates of motor dysfunction in schizophrenia. This research is based on a model which assumes that striatal pathology contributes to both psychotic symptoms and hyperkinetic movement abnormalities. Specifically, we propose that DA activity triggers the behavioral expression of striatal pathology, and that stress exacerbates this process through the effects of the HPA axis on DA release. The educational goals of the application are related to this model. They include further study in the general area of psychoneuroendocrinology and collaborative work on the development of animal models.